COMPARISON OF EXTENDED-RELEASE LOVASTATIN TO CONVENTIONAL LOVASTATIN

To compare the safety, tolerability, efficacy, and plasma profile of two lovastatin er 40 mg formulations to conventional lovastatin 40 mg in hypercholesterolemic patients.